Recording central blood flow velocity waveform by conformal ultrasonic devices

PROJECT SUMMARY
This proposed project aims to develop a soft wearable transducer array for continuous, accurate, and non-
invasive measurement of blood flow velocity waveforms. The blood flow velocity waveform can provide critical
information about the major organ activities and psychiatric state changes, which would help raise patient
awareness, assist preventive care, and serve as the basis for personalized medicine. Conventional
measurement protocols include catheter implants, which is invasive and risky, and Doppler ultrasonography,
which is heavily user-dependent and often has errors and artifacts. This research is distinct from the existing
methods, because it offers several unique features. First, due to its low-profile form factors, the wearable
ultrasonic device enables continuous measurement of the blood flow velocity waveform without constricting the
natural movement of the subject. Second, this device has similar mechanical properties to the human skin and
therefore can achieve a conformal and intimate contact with the skin, which allows accurate and stable
measurements. Third, the phased array control mechanism facilitates focusing and steering the ultrasonic
beam at any locations with predefined incident angles, which enhances the signal-to-noise-ratio and removes
user errors for manual operations. Towards that end, by combining materials science, mechanical design, and
electronics integration, we will use an iterative design of experiments to understand and optimize the
performance of a single ultrasonic transducer. Then, we will develop phased array control mechanism on a
wearable platform to achieve ultrasonic beam focusing and steering. After that, we will integrate the stretchable
transducer array with the phased array control circuit to achieve continuous and accurate recording of blood
flow velocity waveforms. The proposed research is the first of its kind to use a soft, stretchable system to
diagnose and monitor deep tissues under the skin. The availability of a comfortable, non-invasive blood flow
monitoring device will make a fundamental difference in how related diseases are diagnosed and treated,
which will have a direct impact on the clinical practices. This wearable device will also shift the public
perception of blood flow monitoring, promote preventive care, and provide unprecedented data streams for
medical professionals, which will translate into significant reductions in associated mortality and healthcare
costs.
!

Public health relevance
PROJECT NARRATIVE Blood pressure and cardiac output is traditionally monitored invasively using catheters inserted into peripheral arteries and the pulmonary artery, respectively. Non-invasive rigid ultrasound probe measurements are user- dependent and are subject to error and artifact. This research aims to develop a soft ultrasonic membrane that enables continuous, accurate, and noninvasive long-term recording of blood pressure and flow velocity waveforms. !